Mechanisms of induction of gastric injury by H. pylori

Project Summary/Abstract
Helicobacter pylori is a highly prevalent pathogen, with 50% of the world’s population infected. All H.
pylori infections at minimum cause gastric inflammation. A fraction of those infected will eventually develop
gastric or duodenal ulcer disease, atrophy, or gastric adenocarcinoma or MALT lymphoma. Gastric cancer is
one of the leading causes of cancer death worldwide, and eradication of the infection leads to prevention or
even regression of gastric cancer. Treatment is becoming more difficult because of widespread antibiotic
resistance. It is not definitively known who will go on to develop advanced disease, although many different
bacterial and host factors have been implicated. The focus of this research proposal is to study mechanisms
related to novel host/bacterial connections that potentially lead to gastric injury. H. pylori is known to cause
epithelial injury, and preliminary data suggest that the bacteria induce downregulation of the Na,K-ATPase,
which is involved with critical transport functions via establishment of an inward sodium gradient and with cell
adhsion. Decreased Na,K-ATPase activity in gastric epithelial cells leads to reduced barrier function and
gastric injury. Downregulation of the transporter by H. pylori targets newly formed pumps and trafficking from
the ER. The mechanism will be further investigated by studying post-translational modifications potentially
induced by the bacteria, by looking at the physiologic consequences of decreased pump expression on gastric
cells, and by further characterizing the mechanism of pump degradation. H. pylori bacterial factors also play an
important role in induction of gastric injury. From the bacterial standpoint, the role of direct H. pylori adhesion in
Na,K-ATPase downregulation will be delineated. Dependence on the virulance factor CagA and the CagPAI
type 4 secretion system (T4SS) will be determined. The role of gastric injury via Na,K-ATPase downregulation
in induction of signaling pathways from stomal cells will be studied in an enteroid-stromal co-culture model. A
NanoString platform will be used to examine gene changes in bacteria and host simultaneously in order to
expand the targets studied in barrier dysruption and ultimately initiation of oncogenesis. Coordinated signaling
systems induced by bacteria and host that impact decrease in Na,K-ATPase will be delineated, specifically as
related to the CagPAI T4SS; known pathways will be explored and novel pathways will be identified via
innovative mass spectometry techniques. Completion of this work will help determine why and how H. pylori
specifically targets the Na,K-ATPase, identify effector molecules aside from CagA that enter cells via CagPAI
to affect Na,K-ATPase levels, and delineate how bacterial factors modified by host proteins induce signaling
cascades, leading to the changes in transporter levels. The goal of this work is to gain new insight into the
mechanism of gastric injury by H. pylori, which will lead to novel therapeutic protective and treatment options.

Public health relevance
Project Narrative Helicobacter pylori infect the gastric mucosa of 50% of the world’s population, leading to gastritis and, in some, gastric or duodenal ulcers or cancer. The proposed study will investigate how H. pylori injure the stomach lining. The results from this study will aid in understanding why and how some people develop advanced disease, including ulcers and cancer, and will help in the development of new treatment regimens or gastric protective measures.